CLINICAL CENTER FOR MONITORING HEALTH IN WTC RESPONDERS

at the top of each printedpageand each continuationpage. RESEARCHGRANT TABLE OF CONTENTS Page Numbers Face Page.................................................................................................................................................. 1 Description,